CANCER CENTER SUPPORT GRANT

This application requests a 5 year renewal of the Cancer Center Support Grant (CCSG) for the Arizona Cancer Center (ACC). The ACC was founded in 1976, has had a CCSG since 1978, and was designated as a Comprehensive Cancer Center by the NCI in 1990. The ACC functions as a matrix center and is a division of the University of Arizona (UA) College of Medicine (Com). The goal of the cancer center is to make major contributions to research related to basic understanding, preventing, diagnosis, treatment and control of cancer as part of the NCI's network of Cancer Centers. The established and proposed new programs of the ACC include Cancer Treatment, Pharmacology, Cancer Prevention and Control, Biobehavioral Oncology Research, Cancer Biology, Cancer Diagnosis, and Immunobiology. In order to support and enhance the research programs, a series of 15 shared services have either already been established previously or proposed for implementation in this CCSG application. The shared services requested include Analytical Chemistry, Behavioral Measurements, Biometry, Clinical Research, Cytogenetics, Dish-washing, Experimental Mice, Experimental Radiation, Flow Cytometry, Genetically Modified Mice, Molecular and Cellular Pathology, Molecular Services, Research Pharmacy, Synthetic Chemistry, and Tissue Culture.